Dissemination of Advanced SPECT-MR Technology to the Molecular Imaging Community

We would like to use this potential administrative supplement support to extend the scope of this ongoing R01 project. As a short-term goal, we would like to incorporate careful engineering considerations to make the system sufficiently robust, reliable, user-friendly, and ready to be transported between a cluster of collaborating labs, the UIUC lab for imaging therapeutic T-cells [1], Univ. of Chicago lab for potentially imaging AD mouse models, and Northwestern University labs for imaging therapeutically-engineered neural stem cells for treating glioblastoma [2]. As a long-term goal, we would like to develop standardized detector and system technology that can be expanded to constructing larger and more diversified imaging systems to benefit a wider community and to maximize the impact of the generous investment from NIH/NIBIB for advancing the field of molecular imaging and drug development.

Public health relevance
We would like to request for the administrative supplement for developing the critical components for ready disseminatation of advanced simultanious MR-SPECT technologies to the molecular imaging community.